High-throughput high-resolution microscopy for phenotypic drug discovery applications

Abstract: A critical challenge of multi-drug resistance (MDR) in cancer treatments calls for innovative
approaches in understanding cell death mechanisms, essential for developing new anti-cancer therapies.
Traditional drug discovery processes, burdened by high costs and durations of 10-15 years, demand efficient
advancements. Our initiative focuses on the development of a novel, cost-effective multimodal microscope,
integrating high-resolution imaging capabilities to observe both morphological and biochemical changes in live
cells. This advancement aims to accelerate the drug discovery timeline by providing insights into non-apoptotic
cell death mechanisms crucial for evaluating new anti-cancer drugs. Central to our approach is the hypothesis
that incorporating fluorescence imaging into a holographic microscope will allow for the direct visualization of
biomolecules, enhancing the identification of cell death processes and refining drug screening models.
Objectives include enhancing an existing holographic microscope with multimodal imaging for detailed cell
analysis and integrating this technology with tumor-on-chip models for personalized therapy assessments.
A pivotal aspect of our research is the emphasis on "point of learning" (POL) microscopy modules, designed to
democratize access to advanced laboratory techniques among undergraduate students, particularly from
underrepresented groups. This initiative aims to supply students with compact, multimodal microscopes,
facilitating hands-on experience and engagement in cutting-edge research from their homes. By focusing on
inclusive education and practical skills development, we aspire to inspire a diverse new generation of
researchers equipped with the tools to tackle future healthcare challenges. Our program supports extended
biomedical research projects, offers publication opportunities, and provides unrestricted access to lab resources
and the principal investigator. This approach aims to develop practical research skills, promote diversity and
inclusivity, and encourage future healthcare careers among minority populations, thereby making a significant
contribution to DEIA in biomedical research.

Public health relevance
Narrative: We aim to innovate a cost-effective, high-resolution, high-throughput microscope, versatile in operating across dual modalities to provide both morphological and structural insights, enabling efficient screening of new drugs designed to combat drug-resistant cancers. This groundbreaking technology promises to accelerate the pace of drug discovery, dramatically lowering both the time and costs involved in bringing new cancer treatments to fruition. Furthermore, our innovative portable microscope will empower us to educate and involve a vast number of undergraduate students, particularly those from underrepresented groups, by enabling research and learning opportunities right from the comfort of their own homes.